Towards a Compositional Generative Model of Human Vision

Understanding object recognition has long been a central problem in vision science, because of its applied
utility and computational difficulty. Progress has been slow, because of an inability to process complex natural
images, where the largest challenges arise. Recently, advances in Deep Convolutional Neural Networks
(DCNNs) spurred unprecedented success in natural image recognition. The general goal of this proposal is to
leverage this success to test computational theories of human object recognition in natural images. However,
DCNNs still markedly underperform humans when challenged with high levels of ambiguity, occlusion, and
articulation. We hypothesize that humans' superior performance arises from the use of knowledge about how
images and objects are structured. Preliminary evidence for this claim comes from the success of hybrid
models, that combine DCNNS for identifying features and parts in images, with explicit knowledge of object
and image structure. These computations occur within a hierarchy, which includes both top-down and bottom-
up processing. The specific goal of the work proposed here is to strongly test whether these computational
strategies, structured, hierarchical representations and bidirectional processing, are used to recognize objects
in natural images. Human bodies are composed of hierarchically organized configurable parts, making them an
ideal test domain. We examine the complete recognition process, from parts, to pairs of parts, to whole bodies,
each in its own aim. Each aim also tests important sub-hypotheses about when and how the computational
strategies are used. Aim 1 examines recognition of individual body parts, testing whether it is dependent on
parsing images into more basic features and relationships, for example edges and materials. Aim 2 examines
pairs of parts, testing the importance of knowledge of body connectedness relationships. Aim 3 examines
perception of entire bodies, testing whether knowledge of global body structure guides bidirectional processing.
In each aim, we first develop nested computer vision models that either do or do not make use of structural
knowledge, to test whether it aids recognition. We then test whether human performance can be accounted for
by the availability of that structural knowledge. We next measure neural activity with functional MRI to identify
where and how it is used in cortex. Finally, we integrate these results to produce even stronger tests, using the
nested models to predict human performance and confusion matrices as well as fMRI activity levels and
confusion matrices. Altogether, this work will strongly test key theoretical accounts of object recognition in the
most important domain, perception of natural images. The work, based on extensive preliminary data,
measures and models the entire body recognition system. The models developed and tested here should
surpass the state-of-the-art, and be useful for many real-world recognition tasks. The proposal will also lay the
groundwork for future studies of recognition impaired by disease.

Public health relevance
This research uses computational, behavioral, and brain imaging methods to investigate how the visual system represents and processes information about human bodies. The studies will reveal how and when people can accurately recognize objects in natural images, how the brain supports this function, and how loss of information, similar to that that accompanies visual disease, may affect the ability to interpret everyday scenes.